Role of PRR14 in Human Sensory Neurons in Oxaliplatin-Induced Peripheral Neuropathy

Project Summary
Chemotherapy-induced peripheral neuropathy (CIPN) is a prevalent and debilitating side effect of cancer
treatment, particularly associated with the use of oxaliplatin (OXA), a platinum-based chemotherapeutic agent.
Oxaliplatin-induced peripheral neuropathy (OIPN) affects up to 90% of patients undergoing treatment,
leading to chronic pain, sensory deficits, and reduced quality of life. Currently, no effective treatments exist to
prevent or reverse OIPN, largely due to an incomplete understanding of the underlying molecular mechanisms.
Our preliminary RNA sequencing data, has identified Proline-Rich Protein 14 (PRR14) as significantly
upregulated in human dorsal root ganglia (DRG) neurons following OXA treatment. PRR14 is implicated in the
PI3K-Akt-mTOR signaling pathway, which is crucial for nociceptor plasticity and the pathophysiology of CIPN.
These findings suggest that PRR14 may contribute to the electrophysiological changes driving OIPN,
representing a novel and unexplored therapeutic target within the druggable proteome.
The goal of this study is to investigate the role of PRR14 in OIPN by characterizing its expression, localization,
and functional impact in human sensory neurons. We propose two specific aims:
1. Characterize the expression and localization of PRR14 in human DRG neurons: We will perform
immunohistochemistry (IHC) on human DRG tissues and immunocytochemistry (ICC) on primary human DRG
cultures to map PRR14 protein expression and determine its colocalization with nociceptors following OXA
treatment.
2. Determine the effects of PRR14 on the functional response of sensory neurons to OXA: Using RNA
interference (siRNA) to knock down PRR14 expression, we will assess neuronal excitability through patch-clamp
electrophysiology in cultured human DRG neurons treated with OXA.
This research directly aligns with the NIH HEAL Initiative's mission to accelerate the discovery of novel pain
targets, specifically within the understudied druggable proteome (PAR-24-197). By validating PRR14 as a key
modulator of OIPN, this project aims to pave the way for new therapeutic interventions, improving the quality of
life for cancer patients undergoing chemotherapy.

Public health relevance
Project Narrative Chemotherapy-induced peripheral neuropathy (CIPN) is a major public health issue, as it affects a large proportion of cancer patients undergoing treatment, significantly diminishing their quality of life by causing chronic pain and sensory deficits. This research seeks to identify Proline-Rich Protein 14 (PRR14) as a novel target for alleviating Oxaliplatin-induced peripheral neuropathy, potentially leading to the development of new therapies that could improve the well-being of CIPN patients and reduce the burden of chronic pain.